Activity-Dependent Regulation of Kv4 Channels

Kv4 channels have been shown to play important roles in modulating neural activity: regulating the integration of high-frequency trains of synaptic input, regulating backpropagating action potentials, and contributing to long-term potentiation. Consequently, mutations that affect Kv4 function/availability have been shown to result in spatial learning defects, seizure behavior, as well as temporal lobe epilepsy. In the last funding period, we showed that expression and turnover of Kv4 channels are affected in three new contexts: in modulating cholinergic synaptic homeostasis, in response to over-expression of human Aβ42, and during normal aging. In the proposed studies, we investigate the mechanisms underlying Kv4 expression during cholinergic synaptic homeostasis. Synaptic homeostasis/scaling is a form of plasticity that has been heavily studied in the last decade as a protective mechanism that counterbalances changes in global neural activity; this likely occurs during physiological processes, such as learning/memory and development, as well as during pathological conditions. We used Drosophila central neurons as a model, and showed that Drosophila α7 (Dα7) nAChRs are up-regulated after cholinergic blockade, thereby enhancing synaptic currents and providing a homeostatic response. We found that this homeostatic response triggered a novel regulatory mechanism — the up-regulation of Kv4 channels, which we showed prevents an “overshoot” of the homeostatic response. We further showed that the up-regulation of Kv4 channels is blocked by transcriptional inhibitors, and is dependent on Dα7 nAChRs and Ca2+ influx. Drosophila continues to be an ideal model system for these studies because of its cholinergic CNS, the genetic tools it offers, its less redundant genome (eg. there is only a single Drosophila NFAT and Kv4 gene, each of which represents a multi-gene family in mammals), and the ability to go from mechanisms of gene regulation to physiological relevance in the intact brain, and eventually, whole animal behavior. The proposed studies will apply new optogenetic approaches to elicit cholinergic synaptic homeostasis in vivo (Aim-1) —something that has not been explored in any system, and which would currently not be feasible in mammalian systems. We will examine underlying molecular mechanisms, including a novel relationship between ?7 nAChRs and Kv4 channels (Aim-2), and inactivity-induced transcription of Kv4 (Aim-3) that is mediated by NFAT (Aim-4). We will also test all molecular mechanisms for their physiological relevance in identified neurons in the intact brain. Our studies are likely to reveal important insights into the underlying mechanisms of cholinergic synaptic homeostasis.

Public health relevance
Kv4 channels have been shown to play important roles in modulating neural activity and mutations that affect Kv4 function have been shown to result in spatial learning defects, seizure behavior, as well as temporal lobe epilepsy. Here, we investigate the mechanisms regulating Kv4 expression during cholinergic synaptic homeostasis, and the physiological consequences of this regulation. Synaptic homeostasis (also referred to as synaptic scaling) is a form of plasticity that has been heavily studied in the last decade as a protective mechanism that counterbalances changes in global neural activity. Although nearly all studies have focused on glutamatergic synapses, there is substantial evidence that cholinergic regions of the brain experience changes in neural activity in multiple pathophysiological conditions; for example, changes in the expression of nicotinic acetylcholine receptors (nAChRs) have been reported in patients and models of Alzheimer’s disease (AD), possibly providing initial protection from a faster decline in cognitive function, but eventually contributing to the progression of AD. Our studies seek important insight into the underlying mechanisms of cholinergic synaptic homeostasis.